Research Education About Cancer and Health (REACH) Core

ABSTRACT
The Partnership Research Education About Cancer and Health (REACH) Core will deliver research
education activities in cancer and health disparities and prepare future scientists to contribute to the
diversification of the biomedical research workforce. The REACH Core has demonstrated exceptional success
in training undergraduate and graduate students, including individuals from Historically Excluded Communities
(HECs) in previous U54 Partnership funding cycles. Based on its experience implementing a variety of
research education programs such as undergraduate (Cancer Research Internship for NMSU Undergraduates;
CRI-U) and graduate (Cancer Research Internship for NMSU Graduates; CRI-G) research internships,
Graduate Health Disparities Course (University of Washington, School of Public Health), and the Health
Disparities Field Experience (renamed the Health Equity Field Experience in the U54-IV), the Partnership will
implement integrated biomedical research education programs with an emphasis on cancer and/or health
disparities research, across a spectrum of academic levels to diversify the scientific workforce contributing to
biomedical and population health research. The Partnership will also provide concurrent and on-going support
for academic and professional goal attainment among all its participants. Formative assessments to measure
strengths and inform areas for improvement of research education activities will be carried out with the
Planning & Evaluation Core. The Partnership will continue to use long-term tracking tools to offer sustained
support to participants and evaluate impact and effectiveness of activities. In response to past program
evaluation and recommendations from the Internal Advisory Committee and external Program Steering
Committee, a portfolio of activities is proposed that prioritize the current needs to promote and heighten cancer
research education that is focused on undergraduate and graduate students at both institutions.
The REACH Core will implement education programs across academic levels and disciplines; provide support
for trainees’ goal attainment that identifies individual-specific needs and interests, opportunities as well as
potential barriers to career advancement; design experiences for trainees that create a sense of community
and belonging both within the Partnership and more broadly in the larger scientific community, and; conduct
assessments of research education activities’ effectiveness, including long-term tracking, to identify
opportunities for innovation and needs for improvement while meeting the diverse needs of participants. These
activities will contribute to the Partnership’s Aims of diversifying the biomedical workforce, creating a more
inclusive and affirmative research environment and enhancing cancer health equity.